In vitro and in vivo screening of MCMs directed against pathogens with pandemic potential

To improve capacity to prepare for and respond to outbreaks by advancing our capabilities to determine the clinical potential of antiviral products. The Antiviral Program for Pandemics (APP) aims to develop a robust pipeline of safe and effective antivirals to combat a variety of viruses with the greatest pandemic potential (https://www.niaid.nih.gov/research/antivirals).